A machine learning based fetal monitoring system to predict and prevent fetal hypoxia.

Project Summary/Abstract:
Although EFM is widely deployed in the United States for most deliveries, it has failed to reduce rates for
hypoxic injuries such as neonatal encephalopathy, despite an increased rate of cesarean sections. This lack of
improvement has been attributed to inconsistent applications of vague guidelines during manual analysis of
EFM tracings. Existing automated tools available in the market to augment physician capabilities take the form
of low-precision simplistic rule-based alerts, which cause alarm fatigue and also fail to deliver improvements.
This project proposes the creation and validation of a machine learning model for prediction of intrapartum fetal
hypoxia with high sensitivity and specificity to address this need. Using a multi-site dataset of 50,000 tracings
coupled with electronic health records, a combination of clinical knowledge and a variety of machine learning
techniques will be used to create a model with leading performance. To clear the high bar set by FDA for
patient safety with a de novo device, this proposal aims to validate this model by demonstrating high sensitivity
and specificity on a held-out portion of this large multi-site data set, along with a user study to demonstrate
improved performance by clinicians with software assistance. After this project demonstrates the safety and
efficacy of this model for patient care, a future Phase II will beta test a software solution integrating this model
in labor and delivery wards. The research plan outlined in this proposal will give obstetricians a valuable
evidence-based tool to help them interpret EFM tracings.

Public health relevance
Project Narrative: This project will deliver a new system to offer new evidence-based insights to physicians caring for pregnant women to improve health outcomes for their babies. By using advanced computational approaches, this system will be able to predict adverse events like stillbirth and brain damage to enable physicians to intervene in a timely way to preemptively improve outcomes. The output of this project will be an intelligent software monitoring system for patients in labor, which will augment the capabilities of obstetricians and improve well-being for newborn babies.